Cerebello-Midbrain Contributions to Negative Symptoms in Psychosis

PROJECTSUMMARY/ABSTRACT
Individuals with schizophrenia spectrum disorders experience a range of symptoms that cause high levels of
functional impairment, thus representing a large personal and public health burden. Therefore, studies evaluating
early psychosis can help to uncover how symptoms of schizophrenia first arise and elucidate more effective
avenues for early intervention. Of particular importance is the examination of negative symptoms (NS), such as
avolition, anhedonia, asociality, and expressive deficits, as they tend to present prior to the onset of positive
symptoms, are more resistant to treatment, and are more strongly predictive of functional outcomes. Mounting
evidence suggests that the cerebellum (Cb) is involved in diseases of disordered socio-affective and volitional
functioning. Further, preliminary findings from stimulation of the Cb midline have shown promise for mitigating
NS in schizophrenia. Despite these converging lines of research, no one, to date, has examined Cb-VTA
connectivity as being a critical substrate in the pathophysiology of specific NS in psychosis. Therefore, the
proposed study will examine the association between structural and functional Cb-VTA connectivity and aberrant
goal-directed, hedonic, social, and expressive functioning. The proposed study will use data from the Human
Connectome Project for Early Psychosis to study first early 16-35-year-olds who represent both affective and
non-affective psychosis manifestation. Via clinical interviews, resting state functional magnetic resonance
imaging (rsfMRI), and diffusion-weighted imaging scans, I will take a multi-modal, computational approach to
understanding Cb contributions to NS in psychosis. Specifically, I will reconstruct the Cb-VTA tract across sagittal
segments of the Cb cortex, and probe for dissociable contributions to distinct NS based on hierarchical Cb seed
regions and examine differences in tract micro- and macrostructure between early psychosis patients and
healthy controls. Next, I will assess for physio-physiological interactions and effective connectivity profiles
between the Cb, VTA and higher-order structures such as the dorsolateral, orbitofrontal, and premotor cortices,
plus the ventral striatum, and amygdala to assess how the Cb-VTA substrate may contribute to perturbations
upstream in the context of distinct NS. Findings from the proposed study have the capacity to provide additional
insight into previously established frontal and reward-related alterations associated with NS, thus providing a
novel framework for understanding the relations between the Cb, frontal lobe, reward mechanisms and NS.
Further, we will explore potential differences in the association between various structural segments of the Cb-
VTA white matter tract and NS across first-episode and control individuals to assess specificity. To complete this
study, a training plan has been developed that consists of formal coursework, workshops, technical development,
and mentorship. This fellowship would allow me to obtain additional training opportunities that would not
otherwise be available to me, so that I may cultivate expertise on functional neuroimaging, reward, Cb functional
anatomy, and psychosis necessary to become an independent cognitive neuroscientist.

Public health relevance
PROJECT NARRATIVE Negative symptoms in psychosis, such as blunted affect, asociality, avolition (i.e., the absence of motivation in the pursuit of goal-directed behavior), and anhedonia (i.e., absence of pleasure), are common in multiple forms of psychopathology associated with poor functional outcomes and tend to be resistant to treatment. Evidence from opto- and chemogenetics suggests that the putative pathway between the cerebellum (Cb) and ventral tegmental area (VTA) can be manipulated to alter several domains of appetitive functioning, but translational work in humans reconstructing this tract and disentangling its behavioral correlates in the domain of negative psychotic symptoms is missing. How the Cb factors into aberrant functional dynamics between the VTA as well as limbic and frontal targets upstream are also still uncharted, and therefore, this study seeks to examine effective connectivity modulated by the Cb-VTA circuit in the context of negative symptoms in early psychosis, thus providing additional insight into previously established neural substrates of volitional and socio-affective functioning, and potentially highlighting a new target for intervention.